Target metabolic vulnerabilities of MDSCs to enhance cancer immunotherapy

Summary MDSCs are one of the major types of immune cells that contribute to tumor-­induced immune suppression and escape from immune elimination. Importantly, MDSCs have been suggested to contribute to resistance to various cancer therapies, including to anti-­CTLA-­4 and anti-­PD-­1 blockade. Hence, targeting MDSCs could be an attractive approach to modulate tumor immunity to improve current cancer immunotherapies. We have very recently reported that phenformin, a mitochondrial respiratory chain complex I inhibitor, selectively reduced proportion of polymorphonuclear MDSCs (PMN-­MDSCs), but not other immune cells in spleens of tumor-­bearing mice. Phenformin also inhibited proliferation of PMN-­MDSCs derived from bone marrow co-­cultured with tumor cells in vitro. Furthermore, PMN-­MDSCs derived from mice treated with phenformin showed attenuated suppressive activities towards CD8+ T cells in T cell proliferation assays. In our unpublished metabolomics profiling studies of PMN-­MDSCs, we have uncovered additional potential metabolic vulnerabilities of PMN-­ MDSCs. Based on these findings, we hypothesize that PMN-­MDSCs possess distinguishing metabolic features. Given the important contribution of MDSCs to tumor immune escape and immunotherapy resistance, we further hypothesize that targeting the metabolic vulnerabilities of PMN-­MDSCs may cooperate with immune checkpoint blockade to unleash T cell responses, leading to improved anti-­tumor efficacy. In aim 1, we plan to characterize the metabolic vulnerabilities of PMN-­MDSCs. We will not only elucidate metabolic features of PMN-­MDSCs that underlie their sensitivity to phenformin, but also identify other metabolic targets of PMN-­MDSCs, such as those involved in the glutamine metabolism. In aim 2, we will assess the therapeutic benefit of combining targeting the metabolic vulnerabilities of PMN-­MDSCs with immune checkpoint blockade in mouse cancer models. We will evaluate the effects of metabolic drugs in combination with anti-­PD-­1 blockade, on the tumor microenvironment and analyze the contribution of PMN-­MDSC modulatory activity of these metabolic drugs using the PMN-­MDSC adoptive transfer approach.

Public health relevance
Project Narrative: Biological drugs that target the immune checkpoint proteins CTLA-4, PD-1 or PD-L1 have shown significant clinical benefits in solid tumors with durable responses, but only in a fraction of patients. Targeting the immune- suppressive activities of MDSCs with metabolic drugs may synergize with immune checkpoint blockade to enhance immune therapy efficacy. If this hypothesis is proven true, our preclinical studies could be promptly translated into clinical trials.